JHU TRAC: Training and Supporting the Next Generation of TB Researchers

Tuberculosis (TB) remains a major global health problem, and advances in the basic and clinical sciences are
urgently needed to make progress towards the World Health Organization’s End TB Strategy goal of reducing TB
deaths by 95% and new cases by 90% between 2015 and 2035. The Johns Hopkins University (JHU) Center for
Tuberculosis Research (CTR) has been a global leader in TB pathogenesis, translational models, diagnostics,
drug development, pharmacology, public health interventions, and epidemiological and economic modeling for
more than two decades. Research emanating from the CTR and JHU has transformed the treatment of TB
infection and disease, elucidated interactions between TB and HIV drugs, validated the efficacy and effectiveness
of new diagnostic tools, and contributed to the development of evidence-based policies for global TB control,
based on the epidemiology and population dynamics of TB. However, to make further progress in efforts to
achieve the END TB goals, additional innovative, cross-disciplinary and impactful research is critical and a new
generation of TB scientists must be recruited and trained. In the current JHU TRAC proposal, we have assembled
a multidisciplinary team of researchers from multiple departments spanning four JHU schools (Medicine, Public
Health, Nursing and Engineering), with complementary expertise in microbial pathogenesis, immunology, animal
models, imaging, clinical epidemiology, pharmacology/pharmacometrics, computational modeling and
biostatistics, in order to optimize training opportunities for junior investigators and support for new,
interdisciplinary collaborations, with the goal of addressing key knowledge gaps in TB research. The JHU TRAC
team comprises 58 researchers, including 33 experienced TB researchers (19 current members of the CTR), 14
senior researchers new to the TB field, and 11 Early Stage Investigators (ESI). The overarching mission of the
JHU TRAC is to advance TB research by promoting innovative, multidisciplinary collaborations and by recruiting,
training and supporting junior Investigators to develop the next generation of leaders in TB research. To this end,
the JHU TRAC will focus on these four areas: 1) Enhance the integration, productivity and impact of JHU TB
research; 2) Provide mentoring, support, and pilot funding (pilot studies are as of yet undefined but can include
those classified as human subjects research and those that include the use of vertebrate animals) for the next
generation of TB researchers; 3) Support TB researchers with direct services from a Clinical Core and three
Scientific Cores; 4) Contribute to the END TB goals through global engagement, training, outreach, and
collaboration with partners in high-burden countries.

Public health relevance
NARRATIVE — JHU TRAC OVERALL To make further progress in efforts to achieve the World Health Organization’s END TB goals, additional innovative, cross-disciplinary and impactful research is critical and a new generation of TB scientists must be recruited and trained. The Johns Hopkins University (JHU) TB Research Advancement Center (TRAC) will provide added value to TB researchers at JHU by bringing together highly experienced researchers across multiple disciplines and representing four JHU schools (Medicine, Public Health, Nursing and Engineering) in order to optimize training opportunities for junior investigators and support for new, interdisciplinary collaborations, with the goal of addressing critical knowledge gaps in TB research.